Physiology of Retinal Degeneration

Project Summary/Abstract
Many patients with retinal degeneration lose vision slowly and retain some visual perception well into
middle age. Photoreceptors in degenerating retina must therefore be able to continue to function for a prolonged
period, and the rest of the retina must be able to adapt to the loss of some cells to preserve visual processing.
Recent research has shown that cones in degenerating retina even without outer segments still respond to light and
form new synapses, showing that degenerating cones can continue to produce signals much as in healthy animals.
For rods, we have little information about how physiology and connectivity are altered as degeneration proceeds.
This knowledge is crucial since most forms of genetically inherited disease are caused by mutations in rod proteins
and proceed first with rod degeneration; and since some proposed therapies envisage introduction of new rods into
the retina. We propose to address this gap in our knowledge by using single-cell recording from photoreceptors and
bipolar cells, first to describe changes in rod function as disease progresses, and then to understand how the retina
maintains visual processing during cell loss. The first Aim of our proposal is to document changes in rod membrane
potential, input resistance, voltage and current light responses, and amplitude and voltage dependence of Ca2+
currents in mouse models of autosomal dominant retinitis pigmentosa, where rod degeneration occurs rapidly or
slowly over a prolonged period. We propose also to make contemporaneous recordings from rod bipolar cells to
monitor light sensitivity, maximum response amplitude, and response nonlinearity, with electrodes filled with
fluorescent dye to document cell morphology. We hope to discover whether rods can maintain responsiveness as
cells are dying, and to understand how rod connections to bipolar cells are preserved. The second Aim of our proposal
seeks to investigate plasticity in the propagation of photoreceptor responses in degenerating retina and to establish
its mechanism. We have long known that synapses within the retina can break and reform in degenerative disease,
but this remodeling has been thought to be deleterious and to limit the ability of degenerating retina to respond to
photoreceptor replacement or other forms of therapy. More recent experiments have indicated that remodeling can
be adaptive: new synapses formed during degeneration can mediate visual detection and produce nearly normal
retinal output provided degeneration has not proceeded too far. We will use physiological recordings to investigate
previous anatomical evidence that rod bipolar cells can synapse with cones after rods have degenerated, or cone
bipolar cells with rods in cone disease. We will explore the function and pharmacology of these connections and
investigate the influence of light responsiveness, glutamate release, and synaptic adhesion proteins on synapse
formation. Our aim is to provide new information about the mechanisms the degenerating retina uses to
accommodate photoreceptor loss with the ultimate goal to help design new therapies for vision restoration.

Public health relevance
Project Narrative Many patients with retinal degeneration lose vision slowly and retain some visual perception into middle age, indicating that photoreceptors in degenerating retina must continue functioning for a prolonged period, and the downstream retina must be able to adapt to the loss of some cells to preserve visual detection. At present, little is known about the physiology of degenerating rods, or about the mechanisms photoreceptors and the downstream retina use to overcome the gradual decrease in rod and cone number. We propose to address these crucial gaps in knowledge by recording directly from photoreceptors and bipolar cells in mouse models of degenerative disease, and by investigating mechanisms of plasticity in the photoreceptors and their connections to bipolar cells, knowledge essential for the design of therapies for restoring vision in degenerative disease.